Mechanisms for DNA Recognition, Scanning and Nucleosome Mechanical Actions by Pioneer Transcription Factors and their Role in Cell Fate Decisions

Project Summary/Abstract
Cell fate decisions occur during embryonic development, morphogenesis, and cell reprogramming. These wide-
spread cellular changes include launching global gene expression programs that are controlled by pioneer
transcription factors (PTFs) which serve as the master regulators of cell fate. Manipulating PTFs is a
fundamental building block for regenerative medicine, while the dysregulation of PTFs is linked to the
development of cancer. PTFs are special since they can recognize their cognate DNA sequence motifs on both
naked DNA and the DNA wrapped into the nucleosomes that form chromatin. The ability of PTFs to bind DNA
sequences within chromatin is thought to facilitate nucleosome unwrapping, either directly or by recruiting
additional factors, to start the transcription programs. The detailed processes that permit PTFs to recognize
cognate sequence motifs on naked DNA or nucleosomes as well as the mechanics of PTFs once bound to
nucleosomes are largely unknown. Perhaps more importantly, PTFs operate on very long genomic regions
containing clusters of imperfect sequence recognition motifs. Removing these clusters destabilizes cell fates in
vivo. However, the function(s) of these imperfect recognition motifs remains a puzzle.
We propose to examine the mechanics of PTF recognition progressions using the DNA binding domain of Wor1
(WOPR) as model for high-resolution biophysical analysis. Wor1 drives the White-to-Opaque cell switch of
Candida albicans, the agent of common human invasive fungal infections. The White-to-Opaque cell switch,
which affects virulence and niche selection in clinical candidiasis, is controlled by an easily manipulated genetic
circuit in vivo.
Based on our previous and preliminary studies on another PTF, the Engrailed DNA binding domain (enHD), we
have formulated the hypothesis that imperfect-motif clusters organize regions in active DNA and chromatin
where PTFs home in on via heterogeneous scanning and promiscuous recognition, and ultimately act on via
binding-induced conformational transitions.
We have also implemented advanced single-molecule detection systems to resolve PTF-DNA dynamic
interactions with µsec resolution at nm precision. These techniques will be used to address the following Specific
Aims: 1) Examine the Conformational Transitions and DNA Reshaping Dynamics of WOPR upon DNA Binding,
2) Resolve the Dynamic Scanning of WOPR with Imperfect-Motif Clustered DNA, and 3) Dissect the Mechanics
of the Interactions of WOPR with Nucleosome DNA. The proposed studies will detail at the molecular level the
DNA recognition processes used by Wor1 that lead to cell fate decisions and cell reprograming in the context of
the White-Opaque cell switch of Candida albicans.

Public health relevance
Public Health Relevance/Narrative Cell fate during human development requires the tight regulation of global gene expression programs that are controlled by pioneer transcription factors (PTFs). These PTFs must recognize specific DNA sequences within very large regions of the chromatin on multiple chromosomes, by yet poorly understood mechanisms. The goal of this research is to understand the mechanistic rules of PTF-DNA recognition within large regulatory regions and how these mechanisms translate to the cellular transcriptional decisions that ultimately lead to global gene regulation.